Unraveling context specificity of translation by elucidating the mechanism of action of auxiliary translation factors

The research in the laboratory focuses on understanding the fundamental mechanisms of translation and
action of ribosome-targeting antibiotics. One of the underappreciated aspects of translation that has transpired
from our studies is its context specific nature. We learned that the ability of the ribosome to decode genetic
information rapidly and efficiently is significantly influenced by the nature of its tRNA and mRNA substrates
and/or properties of the polypeptide being made. Specific sequences have been identified as difficult to
polymerize but, more than likely, there are many other that also present an obstacle for the translating ribosome.
Why some sequences are challenging for translation and what mechanisms exist in the cell to help the ribosome
overcome such problems are questions that have remained unanswered.
Several conserved auxiliary translation factors (auxTFs) encoded in the bacterial genomes are thought to
assist the ribosome in synthesizing proteins during fast growth or under stress, likely facilitating translation of the
problematic sequence motifs. However, our knowledge of the nature of the sequences whose translation is
facilitated by the auxTFs, about the molecular mechanisms of their action and of their physiological significance
is limited at best. Answering these vexing questions is the goal of the proposal.
We will use crosslinking-based ribosome profiling (XLRibo-seq) to map the genomic sites where auxTFs are
recruited to the ribosome. Guided by these genome-wide data, we will select the most revealing gene models to
dissect in vitro the precise nature of the problematic sequence motifs and elucidate the molecular mechanisms
of the auxTF action. The inferred mechanisms will be validated in vivo and the physiological role of the auxTFs
will be deduced by following the expression of specifically designed reporters under suitable growth conditions
or using the appropriate mutants.
The overall experimental approach will be first optimized using, as a model system, translation termination
factors RF1 and RF2, and then applied to four most intriguing auxTFs (LepA, EttA, BirA and HflX) whose
specificity, activity and physiological role remain enigmatic despite being investigated previously by other
techniques. The approach could be extended to several other known or suspected auxTFs and even to the main
translation factors whose activity could be conceivably modulated by the context of the translated sequence.
The innovation of the proposal stems from the development of new methodologies (XLRibo-seq) with a broad
application to studies of basic mechanisms of translation, and from revealing the functions and molecular
mechanisms of action of conserved proteins playing important roles in expression of genetic information.
The experiments build upon the long-term interests, previous findings, and expertise of our research group.
The project will provide new training and teaching opportunities and facilitate the outreach activities of the lab.

Public health relevance
Even though the ribosome has evolved to make all the cellular proteins, synthesis of specific polypeptides can be problematic. Cells produce special accessory factors to assist the ribosome in synthesizing the difficult- to-make proteins, but how these factors work and when their help is needed is unknown. Finding the functions of the molecular aids of the ribosome will advance our understanding of the fundamental mechanisms of protein synthesis and provide foundation for developing new medicines and treating diseases related to faulty protein expression.